Gut-brain axis in metabolic disease

Project Summary/Abstract
A wide range of evidence points to the critical role that signals from the gut, acting in the CNS, play in
the regulation of food intake, body weight and the disposition of metabolic fuels including glucose. Some of the
most powerful evidence for the critical nature of this “gut-brain” axis comes from direct manipulations of the GI
tract that occur during various bariatric surgical procedures. These procedures are often thought of as
“restrictive” or “malabsorptive”, however, it is clear that the potent effects of these procedures to reduce body
weight and glucose levels are the product of altering the activity of the gut-brain axis. The important point is
that manipulation of the gut via these surgical interventions provides the largest and most sustained weight
loss in individuals with obesity compared to any other therapeutic option. Thus a better understanding of the
gut-brain axis is crucial for the development of new, less invasive and more scalable solutions to treat obesity.
While the importance of the gut-brain axis is clear, our understanding of how this axis works remains
incomplete. This program project grant will bring together a range of experiences and technical approaches
under a single coordinated project that will allow for rapid understanding of the impact of gut, neural and
hormonal signals on their crucial targets within brainstem neural circuitry. To that end, the current projects will
utilize advanced neuroanatomical tracing, electrophysiology, activation and silencing of circuits, next
generation sequencing and apply all of these methods exclusively in molecularly defined cell-types using a
broad range of mouse models we have developed. These approaches will be combined with a range of
behavioral and physiological measures of food intake, energy expenditure and GI function. Finally, we will
bring to bear advanced surgical approaches that allow for assessment of the impact of bariatric surgery in
these mouse models.
The ultimate goal of this project is to identify key aspects of how the GI tract impacts these neuronal
circuits, the identification of key neuronal populations that are the target of those GI signals and how each
population can influence food intake, body weight and regulate GI function. The guiding hypothesis is that the
signals generated and the neural circuit engaged by toxins and those by normal presentation of nutrients to the
GI tract will be distinct in several key regions of the brainstem. The detailed understanding of these parallel
circuits will allow for a better understanding of existing therapies that target the brainstem and the development
of entirely new therapeutic strategies that appropriately engage this circuitry in a manner that is similar to what
happens after bariatric surgery.

Public health relevance
Narrative A wide range of evidence points to the critical role that signals from the gut, acting in the brain play in the regulation of food intake, body weight and gastrointestinal function. This program project will use state-of- the-art techniques to label and manipulate the neurons that are the direct targets of signals from the gut to identify new targets for the treatment of obesity.